Cancer Prevention and Control Research Program

PROJECT SUMMARY/ABSTRACT
Markey Cancer Center's (MCC) Cancer Prevention and Control (CP) Research Program unites highly
complementary strengths in the areas of population-based research and community-based cancer control
research with the overarching goal of reducing cancer disparities in Kentucky with an emphasis on the state's
Appalachian and rural populations. Kentucky has the highest overall cancer incidence and mortality rates
among all 50 United States. Alarmingly, the cancer incidence and mortality rates in Appalachian Kentucky are
far higher than the rates for the non-Appalachian area of the state. These elevated rates are driven by a variety
of underlying factors including low socioeconomic status, low educational attainment, high risk behaviors,
cultural barriers, and environmental exposures. Strengths of the CP program include studies focused on
uncovering the role environmental exposures play in Kentucky's high cancer incidence rates, testing
intervention programs that address unique cultural barriers, and smoking cessation policy development
initiatives. CP program members are also national leaders in developing population-based methods and
measures that facilitate inter-programmatic cancer research. The CP program combines these strengths to
address 3 thematic areas: identification of social, cultural, behavioral, genetic and environmental factors that
contribute to the elevated cancer incidence and mortality rates (Theme 1); design, testing, implementation and
evaluation of intervention strategies that address identified risk factors (barriers) and reduce the cancer burden
(Theme 2); and development of population-based methods and measures that facilitate inter-programmatic
cancer research directed at more precisely identifying the distribution of treatment patterns and biomarkers in
the population (Theme 3). Most recently, the CP program recruited 2 National Cancer Institute-funded cancer
molecular epidemiologists to build on its unique research resources. The current 28-member CP team draws
from 5 colleges and 12 departments at the University of Kentucky, thus promoting active interdisciplinary
translational research. CP productivity is reflected by total annual external cancer-related funding of over
$9.7M ($6.7M annual direct costs) and 245 total publications in the current funding period, 30 (12%) of which
are inter-programmatic, 83 (34%) intra-programmatic and 162 (66%) inter-institutional. CP research
encompasses all segments of the cancer control continuum: prevention, early detection, treatment and
survivorship. CP studies address a number of cancer sites including those that disproportionately contribute to
Kentucky's high cancer burden (i.e. lung, colon, breast and cervical cancers). Thus, the CP program is integral
to achieving the overall MCC mission to reduce cancer morbidity and mortality in the Commonwealth.